Using Differences in Perceived Legitimacy and Resident Compliance to Promote Fair and Effective Implementation of Smoke Free Housing

Project Summary
Smoke-free housing (SFH) has recently been mandated by the U.S. Department of Housing and Urban
Development (HUD) to protect public housing residents from secondhand smoke (SHS) exposure.
However, our preliminary work suggests that SFH might not be effective. In focus groups, smokers in
low-income housing have reported to us that they are primarily motivated by fear of punishment, rather
than an obligation to comply with SFH, which they perceive to be unfair. They describe a situation in
which many smokers respond by hiding their smoking inside their apartments—where they think they will
be less likely to be seen—when compliance with SFH is perceived to be an inconvenience or even
unsafe (e.g., if they would have to walk across their community at night to smoke off the property). This
suggests that the perceived legitimacy of SFH is low—residents feel so strongly about its unfairness that
they are unlikely to comply with it on their own. This means that efforts to increase resident compliance
by relying on threats of punishment could be counterproductive. Residents also report several barriers to
compliance with SFH that they also perceive to be unfair (e.g., banning smoking in public housing but
allowing it on other types of properties). These barriers vary between housing authorities and represent
important differences in SFH implementation strategy.
Principles and approaches from community-based participatory research guide this study. In Aim 1 we
assess factors associated with perceived legitimacy and compliance across six housing authorities. We
will use a mixed methods approach to establish: (1) who exhibits lower perceived legitimacy of SFH, and
under what circumstances, and (2) what property and organizational factors that differ between and
within housing authorities could affect SFH implementation and resident compliance. In Aim 2 we test
associations between perceived legitimacy, SFH implementation strategy, and several markers for SHS
(fine particulate matter, airborne nicotine, and exhaled CO). We hypothesize that: (a) perceived
legitimacy will be related to differences in SFH implementation, (b) differences in SFH implementation
strategy will affect SFH compliance, as measured by SHS, and (c) low perceived legitimacy of SFH will
mediate the impact of implementation strategy on SFH compliance. In Aim 3 we develop a scalable
implementation strategy for SFH that to improve resident compliance and perceived legitimacy.
Community advisory boards will be used to inform this process to ensure that solutions are grounded in
real-world experiences.

Public health relevance
Project Narrative Smoke-free public housing policies have been mandated by the U.S. Department of Housing and Urban Development (HUD). However, our work suggests these policies are considered to be so unfair by residents that compliance is severely undermined, with potentially negative unintended consequences. Our goal is to verify how these policies can be harmful and propose adaptations to increase their effectiveness.